Design And Synthesis of Immunomodulators And Vaccine Con

We have designed and prepared a number of antibody-dextran conjugates that have been employed by Dr. Patricia Mongini at NY University in experiments aimed at exploring how the mode of presentation of an antigen at the B cell surface affects activation thresholds and other cellular events (cell cycle progression and apoptosis) that follow activation of resting, mature human B cells. Using our co-conjugates of anti-IgM (surrogate for antigenic determinants) and anti-CD21 (surrogate for complement C3d, ligand for the CD21:CD19:CD81 B cell complex), Dr. Mongini demonstrated that T-dependent antibody responses can be significantly enhanced via polyvalent co-ligation of the B cell receptor with the CD21 complex as occurs when B cells are stimulated with an antigen-complement complex (see, Mongini et al., 2001). This past year, we prepared double conjugates of anti-IgM and anti-CD21 on soluble, high molecular weight dextran that Dr. Mongini employed for studying the empact of co-engagement of the corresponding receptors in the presence of IL-4 on B cell expression of molecules critical for T cell activation, namely, CD80 and CD86. Significantly heightened expression (upregulation) was observed. Thus, co-clustering of B cell receptors and CD21 (CR2) plus added IL-4, following exposure to complement complexed with microbial or self antigens, will enhance B cell recruitment of T cell help. Additionally, Dr. Mongini, using our double conjugates to co-engage the B cell antigen receptor (BCR) and the CD21/CD19/CD81 co-stimulatory complex, showed that this signal can enhance the escape of human B cells from Fas-induced death (apoptosis). It was established that BCR:CD21 co-ligation lowers the BCR engagement necessary for inducing protection from Fas apoptosis. Enhanced protection was associated with altered expression of several molecules known to regulate Fas apoptosis and dampened expression of membrane Fas on B cells. Dr. Mongini further showed that, with double conjugates anti-IgM and anti-CD21, strong synergy occurred in regard to human B cell cycle progression, proliferation and viability of daughter cells when co-stimulated with the cytokines, IL-4 and BAFF. These effects were considerably enhanced when BAFF was added in addition to IL-4.